Myeloid Cell Diversity: From Fundamental Biology to Disease States

ABSTRACT
Support is requested for a Keystone Symposia conference entitled Myeloid Cells: Mechanisms, Diversity and
Function, organized by Drs. Andrés Hidalgo, Daniela Quail and Lai Guan Ng. The conference will be held in
Banff, Canada from January 28-31, 2024.
Myeloid cells are major components of the innate immune system that are first responders to inflammatory
cues and critical to engage long-lasting adaptive immune responses. Understanding the fundamental biology
governing myeloid development and function in steady-state and inflammatory contexts is imperative to
developing treatments to combat cancer, cardiovascular disease, neurodegeneration and other diseases. With
the rising use of single cell technologies, the vast extent of myeloid diversity and heterogeneity is being
unveiled for the first time, creating new knowledge gaps surrounding myeloid functional states in health and
disease. This Keystone Symposia conference will explore transformative research concepts that challenge
current views of myeloid biology. The conference program was designed to leverage cutting-edge imaging
technologies to learn about myeloid innate immune functions across tissue environments. It will also promote
discussions that will reevaluate the fundamental biology underlying myeloid development in steady-state and
inflammation, as well as challenge current concepts of how we define myeloid cell subsets versus functional
states. The program will also include sessions that will consider the impact of trained immunity or lifestyle on
myeloid states in health and disease and discuss emerging concepts in metabolic regulation of myeloid cells in
disease and aging. Attendees will learn about new tools and resources that are available to study the diversity
of myeloid states in various experimental contexts and will be challenged to rethink existing dogma that
underestimates the breadth of myeloid cell contributions to health and disease.

Public health relevance
PROJECT NARRATIVE Myeloid cells are major components of the innate immune system that are first responders to inflammatory cues and critical to engage long-lasting adaptive immune responses. This Keystone Symposia conference will cover fundamental advances on myeloid cell biology, and their implication in inflammation, aging, cancer and metabolic disorders. This meeting will provide a venue that will enable discussion on how these emerging factors influence immune function, generate myeloid cell heterogeneity, and drive disease.